LOPID IN PATIENTS WITH NONINSULIN DEPENDENT DIABETES MELLITUS

The objective is to determine if Lopid reduces triglyceride levels in patients with noninsulin dependent diabetes mellitus independent of diabetes control and nutritional regulation.